Right Heart Function in Health and Chronic Disease

Heart failure and chronic obstructive pulmonary disease are common in Veterans and frequently complicated by
pulmonary hypertension and right ventricular failure (RVF). Pharmacologic treatments for RVF are limited.
Recent studies suggest that powerful cardioprotective effects are mediated by α1-adrenergic receptors, in
particular the α1A-subtype (α1A-AR). Our preliminary data show that chronic stimulation of α1A-ARs (for 2 wk)
had major beneficial effects on RV function in two models of RVF induced by pulmonary fibrosis or pulmonary
artery constriction (PAC). The therapeutic effect was closely linked to reversal of mitochondrial dysfunction. This
renewal project will determine the mechanisms involved in α1A-AR-mediated reversal of mitochondrial
dysfunction and reversal of RVF. Moreover, in translational studies using human engineered heart tissue (EHT)
we will determine if chronic α1A-AR agonism increases mitochondrial function and increases contraction of
human EHT. This renewal project will build on the following recent preliminary results:
1. In a model of RVF induced by PAC, RVF was reversed by chronic treatment with a highly specific α1A-
AR agonist at a low dose that did not raise blood pressure.
2. Reversal of RVF involved increased myocardial ATP levels and an increased rate of mitochondrial
respiration, which indicated protective effects on mitochondria.
3. We recently reported that contractions of RV myocardium in-vitro are significantly inhibited by the low
ATP levels observed in RVF. This suggests that ATP level is a critical determinant of RV function.
4. Reversal of RVF involved increased levels of antioxidant enzymes, decreased levels of reactive oxygen
species (ROS), and decreased ROS-modification of muscle proteins.
5. Reversal of RVF also involved reversal of hyperacetylation of multiple proteins.
6. In translational studies, we used human EHT created using human induced pluripotent stem cell-derived
cardiomyocytes (iPSC-CMs). We recently reported that the α1A-AR is expressed in human EHT.
Moreover, chronic α1A-AR agonism for 2 wk caused increased contraction of human EHT.
These novel observations suggest 3 hypotheses that will be tested in 3 Specific Aims:
1. Chronic α1A-AR agonism increases mitochondrial respiration rate and ATP production both by increasing
cellular antioxidant defenses and by reversing hyperacetylation of mitochondrial proteins.
2. Recovery of mitochondrial function drives recovery of myofilament contraction and reversal of RVF by a)
increased bioenergetic status (e.g. increased ATP level), and b) decreased myofilament damage.
3. Chronic α1A-AR agonism increases mitochondrial and myofilament function of human EHT.
Aim 1. Determine the mitochondrial mechanisms driving reversal of RVF by chronic α1A-AR agonism. In
the setting of RVF, we will determine the specific mitochondrial processes that are improved by chronic α1A-AR
agonism (Aim 1A), and determine the roles played by increased antioxidant defense (Aim 1B) and reversal of
mitochondrial protein hyperacetylation (Aim 1C).
Aim 2. Determine the myofilament mechanisms driving reversal of RVF by chronic α1A-AR agonism. In
the setting of RVF, we will determine if chronic treatment with α1A-AR agonist causes rescue of myofilament
function by: a) increasing bioenergetic status (e.g. more ATP); and/or b) decreasing damage to cardiac
myofilaments (e.g. involving ROS or acetylation).
Aim 3. Determine if chronic α1A-AR agonism increases mitochondrial function and myofilament function
of human engineered heart tissue. As an approach to testing the effects of chronic α1A-AR agonism in human
cardiomyocytes, we will use human EHT, and we will determine if chronic α1A-AR agonism causes increased
mitochondrial function and increased myofilament function.

Public health relevance
Heart failure and chronic obstructive pulmonary disease are extremely common in Veterans and commonly complicated by pulmonary hypertension and right heart failure. Treatment options for right heart failure are very limited. Heart failure has been the number one reason for admission among patients in the Veterans' Health Care System. Recent studies show that patients with post-traumatic stress disorder (PTSD) are at increased risk for cardiovascular disease, and PTSD is twice as prevalent in veteran populations versus the general population. The Department of Veteran Affairs Quality Enhancement Research Initiative (QUERI) is designed to improve care using research evidence to improve clinical practice for high-risk and/or highly prevalent diseases or conditions among veterans. Congestive heart failure is one of the high-risk, and highly prevalent diseases included in the QUERI program. Thus, research in cardiovascular disease, and RV failure in particular, are extremely important and relevant to the mission of the VA.